Mechanistic Inflammatory Pathways in Graft Versus Host Disease

PROJECT SUMMARY
Graft versus host disease (GVHD) is the major complication associated with allogeneic
hematopoietic stem cell transplantation (HSCT). Pathological damage to the skin,
gastrointestinal tract, and liver are hallmarks of this disease; however, GVHD can also induce
inflammation in the central nervous system (CNS) as well as cognitive and behavioral alterations
in patients. We previously observed that host interleukin 6 (IL-6) production and the associated
expansion of CNS resident macrophages (microglia) appear to have critical roles in the induction
of neuroinflammation, but that blockade of IL-6 signaling does not completely mitigate disease
severity. In preliminary studies, we have now identified endocannabinoid signaling through the
type 2 cannabinoid receptor (CB2R) and the kynurenine metabolic pathway as novel IL-6-
independent mechanisms by which inflammation is propagated in the brain. The overall goal of
this proposal is to validate and characterize these two putative mechanistic pathways by which
GVHD induces inflammation in the brain and ascertain how they modulate systemic
manifestations of this disease. Our overall hypothesis is that inflammation during
GVHD is attributable to CNS resident macrophages which induce inflammation
and behavioral dysfunction through both the endocannabinoid signaling and
kynurenine metabolic pathways. Studies in Specific Aim 1 will define the effect of CB2R
signaling blockade on CNS and systemic manifestations of GVHD. We will employ
pharmacological and genetic approaches that directly antagonize CB2R receptor signaling or
inhibit the synthesis of 2-AG, the natural endocannabinoid ligand of the CB2R, to address this
question. Experiments in Specific Aim 2 will determine whether expression of the CB2R on CNS
resident macrophages is critical for mediating GVHD-induced inflammation. We will utilize novel
CB2Rfl/fl mice which have flanking lox p sites which will allow for cell-specific deletion when bred
with appropriate lineage-specific Cre animals. Studies in Specific Aim 3 will define the role of
the kynurenine pathway in the pathophysiology of CNS and systemic inflammation that occur
during GVHD. We will determine whether CNS resident macrophages are the dominant source
of neurotoxic kynurenine metabolites, and define whether inhibition of this pathway using both
genetic and pharmacological approaches prevents inflammation in the brain and periphery. The
overall goal is to define relevant biochemical and immunological pathways that are responsible
for GVHD-associated neuroinflammation in order to foster the development of clinically relevant
strategies to mitigate this complication in allogeneic HSCT patients with blood cancers.

Public health relevance
PROJECT NARRATIVE Graft versus host disease (GVHD) is one of the major complications associated with allogeneic hematopoietic stem marrow transplantation (HSCT), and can lead to significant long term cognitive and mood changes, as well as neurological impairment, in patients who are otherwise cured of their disease. The goal of this project is to define critical inflammatory and biochemical pathways which mediate neuroinflammation during GVHD in order to increase our understanding of this complex pathophysiologic process. The ultimate objective of this proposal is that, through these preclinical studies, we will gain new insights into this disease which will lead to the development of novel clinical approaches for the treatment of this complication after allogeneic HSCT.